Infection-Associated Cancer Research Training Program in Mali

PROJECT SUMMARY The Northwestern University (NU) and Mali’s University of Sciences, Techniques, and Technologies of Bamako (USTTB)’s Infection-Associated Cancer (NM-IAC) Research Training Program addresses a National Cancer Institute (NCI) high research priority and a significant and growing source of morbidity and mortality in sub-Saharan Africa, particularly in Mali. In 2018, the four most common infection-associated cancers (IACs; cervical, liver, gastric and lung cancers) represented more than a quarter (27%) of all registered cancers in Mali. The NM-IAC Program seeks to build an interdisciplinary, collaborative, research training program to train researchers in the conduct of population-based cancer epidemiology and molecular studies and advance the discovery of unique population-specific risk factors and biomarkers for the development of risk stratification and screening tools of individuals with underlying infections at increased risk of associated cancers, with the ultimate goal of improving detection, treatment, and outcomes. The NM-IAC Program will leverage our team’s extensive experience in conducting NIH-funded global health research training programs in Africa, program refinements, and highly successful training resources and outcomes from our decade-long, research-training collaboration between USTTB and NU. Our central hypothesis is that building capacity in the key disciplines involved in IACs will empower Malian and US investigators to develop and implement novel, contextually appropriate, and culturally adapted risk stratification and screening tools. To achieve our goals, our specific aims are to (1) Train two (2) PhD-level cancer epidemiologists, each with a focus on one of the four IACs and capable of (i) designing and conducting population-based cancer epidemiology studies; (ii) developing protocols for biospecimen collection, processing, and storage; and (iii) evaluating population-specific biomarkers for use in screening and identifying “at-risk” populations; and Two master’s-level molecular pathologists, one biostatistician, and one bio-informatician, capable of (i) collecting and managing clinical, laboratory, and population-level specimens and data; (ii) using virtual modalities for training, education, and mentoring and telepathology for distance microscopic diagnostics and training; and (iii) performing comprehensive biostatistical and bioinformatics analyses, generated from population-level studies; (2) Enhance the knowledge and skills of existing faculty, particularly early career faculty, to contribute to and participate in interdisciplinary research teams of mechanistic and population-based studies of IACs through medium-term intensive workshops and mentored research projects led by the scientists trained in Aim 1; and (3) Optimize engagement of public health scientists, clinicians, and health system stakeholders through workshops and seminars to disseminate knowledge about the novel epidemiological and biomarker tools and strategies, for use in new programs focused on the prevention and detection of IACs in Mali.

Public health relevance
NARRATIVE In Mali, the 8th largest African country, a low- and middle-income countries (LMICs) located in West Africa, infection-associated cancers (IACs) are increasing and represent more than a quarter (27%) of all cancers. Few African scientists have the epidemiological, molecular pathology, biostatistics and bioinformatics training needed to design and conduct population-based and mechanistic studies on IACs. This research training program will capitalize on a decade of collaboration between Malian and US investigators to create capacity to develop and implement new contextually appropriate and culturally adaptive strategies to reduce in incidence, morbidity, and mortality of IAC in Mali and other LMICs in the region.